Human islet-derived, islet-reactive T cells from subjects with Type 1 diabetes

PROJECT SUMMARY/ABSTRACT Understanding the autoimmune response in human type 1 diabetes (T1D) is crucial for the design of successful immunotherapies for those at-risk for the disease as well as for those with established disease. While studies of rodent models of have greatly instructed us on the autoimmune process, the translation of successful therapies and prevention studies in the rodent models to human clinical trials has been far less successful. While we know much information concerning islet infiltrating T cells in the rodent models and islet infiltrates in humans with T1D by histology and immunohistochemistry, we previously have not had the opportunity to isolate directly the lymphocytic infiltrate from human with T1D for repertoire analysis and functional capacity. We have received islet isolations from 7 individuals with T1D and have grown or sorted directly out of the islets, 95 CD4 and CD* T cell lines. We have demonstrated the reactivity and HLA restriction of 4 CD4+ T cell lines and 3 CD8+ T cells lines (multiple reactivities are represented). The purpose of this proposal is to assay each T cell line for reactivity to whole normal islets, whole islet proteins, known islet- associated peptide targets of autoreactive T cells, to peptides derived from islet proteins that bear post- translational modifications, to define their HLA restriction, and define their effector functions. These islet- infiltrating T cells will be vital tools/reagents for investigators in the field to study the function of islet-infiltrating T cells in humanized mouse models of T1D, T cell receptor repertoire, to preserve autoreactive T cell receptors for future studies, in functional assays of autoreactive T cell interactions with T regulatory cells, B cell, antigen presenting cells and the innate immune system. Finally, these studies will inform investigators in the design of successful immunotherapies for those at-risk for T1D and especially for those with established T1D.

Public health relevance
PROJECT NARRATIVE In type 1 diabetes (T1D), CD4 and CD8 T cells enter the Islets of Langerhans in the pancreas and destroy the  cells, the cells responsible for making insulin. This disease can be managed with administration of insulin, but left untreated, this is a fatal condition. While we have learned much about the autoimmune process in the rodent models of T1D, successful therapies for in these models has translated well to the human disease. By necessity, studies of human T1D have been mostly limited to peripheral blood, however, we now have the rare opportunity to examine T cells grown or sorted directly from islets of individuals with T1D. To date, we have 7 such samples and have isolated 95 CD4 and CD8 T cells and we have determined the autoreactivity and HLA restriction of 7 of these cell lines. The goal of this study is to examine the remaining lines (and lines from newly received cases) for autoreactivity, HLA restriction and phenotype. This information will be used by investigators to study autoreactive T cells interactions with other cell types important in T1D and to inform the design of immunotherapies for success in targeting these autoreactive T cells in T1D.